Dissecting the molecular mechanism of ketogenic metabolites in AD

PROJECT SUMMARY
Alzheimer’s disease (AD) is a fatal, progressive neurodegenerative disease affecting a total of 6.5 million
Americans over the age of 65, with that number growing each year as our population ages. There is currently no
prevention nor cure for AD, and only a handful of drugs that slow, but do not stop, the disease’s progression.
The AD brain is marked by accumulation of amyloid β plaques, tau neurofibrillary tangles, and lipid droplets.
Recent studies report brain and whole-body metabolic dysfunction in AD, to the extent that glucose insensitivity,
insulin resistance, and metabolic hormone dysregulation are nascent hallmarks of AD. Additionally, metabolic
syndromes such as type 2 diabetes, obesity, and hypertension are significant risk factors for the development of
AD. The contemporary understanding of AD as a metabolic disorder has sparked a growing interest in
metabolism-based therapy. One such therapy, the ketogenic diet (KD), a high-fat/low-carbohydrate diet, is
increasingly being studied in the context of AD and has shown promise in preclinical and clinical trials. However,
the potential of the KD as a treatment for AD is marred by variable efficacy, low compliance, and side effects
outweighing benefits. The molecular mechanisms by which the KD ameliorates AD pathology are unclear and
warrant further study, and potential mechanisms include inhibiting carbohydrate metabolism, increasing fat
metabolism, and altering amino acid (AA) metabolism. My F99 phase (Aim 1) of this proposal will focus on β-
hydroxybutyrate (BHB), the primary ketone body produced by KDs, which can act on the body in two main ways:
metabolism for energy and signaling. I will disentangle these molecular features of BHB (1.1) in vivo via
transgenic mouse models and (1.2) in vitro via orthogonal validation of candidate pathways identified in neuronal
tau interactomics. My K00 phase (Aim 2) will expand to AAs, specifically looking at isoleucine (Ile) restriction
and dissecting the effects of Ile on protein synthesis (2.1), signaling (2.2), and metabolism (2.3) in the context of
AD and brain aging. The unifying goal of this F99/K00 proposal is to use the KD as a starting point for the
development of novel metabolic therapies for AD and brain aging by (1) identifying the bioactive components of
the KD that are necessary and sufficient for its benefits in AD and brain aging and (2) disentangling the
convergent and divergent mechanisms of action of dietary metabolites in AD and brain aging. This F99/K00
proposal will enable my long-term goal of establishing an independent lab that applies pharmacological, genetic,
and mass spectrometry approaches to dissect the molecular underpinnings of metabolic interventions in AD and
brain aging.

Public health relevance
NARRATIVE Alzheimer’s disease (AD) is the most common cause of dementia and is characterized by progressive memory loss, cognitive impairment, behavioral changes, and eventually, death. While several FDA-approved drugs exist that may alleviate disease pathology, there is currently no prevention nor cure for AD, although metabolism- based therapies including the ketogenic diet hold great promise. The goal of this proposal is to identify which molecular components of the ketogenic diet are necessary and sufficient for benefits in AD and non-pathological brain aging and to determine their mechanisms of action.